Technical Support for the SEER Training Website (STW), New Data Item Feasibility, and Workshops for Advanced Topics for Cancer Registrars

Abstract/Specific Aims The purposes of this contract are to provide support to the NCI for: (1) the update and enhancement of the STW CRSMs and obtaining feedback from CTRs regarding the modified STW content at the National Cancer Registrars Association 2019 Annual Conference, (2) feasibility testing of proposed new data items, and; (3) the 2019 SEER Advanced Topics for Registry Professionals meeting.